Adenoviral Vector-based Pandemic Influenza Vaccine

PROJECT SUMMARY
The ability of both low and highly pathogenic avian influenza (HPAI) viruses of H5, H7, and H9 subtypes to
repeatedly infect humans reveals their zoonotic nature and pandemic potential. Besides, the seasonal influenza
viruses (H1N1, H3N2 & influenza B) continue to evolve and pose significant public health threats worldwide.
While candidate vaccine viruses can be made for individual influenza strains, it is impractical to prepare
significant vaccine stocks for each of the potentially pandemic viruses. The significance of developing a universal
influenza vaccine is of utmost importance for developing a better strategy for combatting seasonal as well as
potential pandemic influenza viruses.
We have developed a novel replication-defective bovine adenovirus (Ad) type 3 (BAd3)-based vaccine
platform, which is better than the currently available Ad vector systems for providing heterologous influenza
protection with dose sparing and is not impacted by the pre-existing human Ad vector immunity. Recently, we
have revealed that the BAd vaccine platform induces significantly higher expression levels of the immunogen
and innate and adaptive immunity-related factors compared to that of human Ad vectors in mice. We have also
identified a 22 amino acid residues Autophagy-Inducing Peptide (AIP) C5 (AIP-C5) from the CFP10 protein of
M. tuberculosis that enhances robust T cell immune responses in mice to NP of H7N9 influenza virus when
delivered through an Ad vector. It conferred complete protection (from disease, death, or lung viral titers) against
H1N1, H3N2, H5N2, H7N9, and H9N2 influenza viruses. Immunization of mice with an Ad vector expressing
H5N1 M2e-HA2 [the extracellular domain of matrix 2 linked to the stem portion (HA2) of hemagglutinin (HA) with
the HA signal peptide and the GCN4 leucine zipper trimerization domain] led to a significant reduction in lung
viral titers following challenge with an H5N1 virus.
This proposal is based on the hypothesis that a combination of heterosubtypic cell-mediated immune (CMI)
responses against NP and the cross-reactive (not necessarily cross-neutralizing) humoral immune responses
against NP or other conserved domains (M2e-HA2), when expressed with AIP-C5 and delivered through the
BAd vaccine platform, will provide broad protection against potential pandemic H5, H7, or H9 avian influenza
viruses as well as seasonal H1, H3, and influenza B viruses. The aims of this proposal are: i) To investigate
immunogenicity and protective efficacy of novel antigen design and vaccine delivery platform in a mouse model
for developing universal influenza vaccines (Aim 1); ii) To ascertain immunogenicity and protective efficacy of
two selected universal influenza vaccine formulations in ferrets (Aim 2); and iii) To monitor virus transmission
from the vaccinated to non-vaccinated animals, the quality of memory B and T cell responses, the durability of
protective and vector immunity, and potential vaccine-associated enhancement of respiratory disease (Aim 3),
utilizing the state-of-the-art technologies.

Public health relevance
PROJECT NARRATIVE Since the nature of the next pandemic influenza virus is unknown, our efforts will be directed towards the generation of a universal influenza vaccine that is broadly protective against H1, H3, influenza B, H5, H7, and H9 influenza subtypes. This universal influenza vaccine should protect against a variety of influenza virus subtypes, available for use before a traditional strain-matched vaccine can be produced, hinder human-to-human transmission, and lower morbidity and mortality rates during the initial stages of an influenza pandemic event. This effort will also help in developing a better seasonal influenza vaccine.